Molecular Regulation of Stem Cell Aging

SUMMARY
The Administrative Core will coordinate the activities of the three Projects and three Cores of
this Program Project. The Specific Aims of the Administrative Core are: 1) to provide
administrative assistance and fiscal oversight to all Projects and Cores B and C; 2) to facilitate
communication both within the Program and between the Program members and other
investigators, centers, programs and institutions; and 3) to establish and maintain an Executive
Committee, a Scientific Advisory Board, and an Internal Advisory Committee. The services
offered by the Core will include administrative and secretarial support (ordering of supplies,
financial reports, assistance with budget management), organization of regular meetings and of
the annual meeting with the Scientific Advisory Board, and preparation of progress reports and
other documents. The Director will oversee and coordinate all activities of the Core. He will meet
regularly with the Administrator and with other Project Leaders/Core Directors to discuss
administrative and managerial issues to insure that the Program is working effectively and
efficiently. The Program Administrator will assist the investigators with financial matters, the
organization of meetings and conferences, and general needs for the proper functioning of the
Program.